Neural mechanisms of foraging decisions

PROJECT SUMMARY / ABSTRACT
Understanding how the brain makes decisions based on noisy sensory information is one of the central goals
of neuroscience, but past efforts to study this process have been hindered by three challenges: (1) Animals
make decisions in complex environments that do not always map onto the simplistic binary decision tasks
typically used in the lab; (2) Decisions are influenced by slowly changing variables like environment value that
are difficult to study in short experiments; (3) Decision making involves a large network of interacting brain
regions, each of which influences and is influenced by many others. The proposed research addresses these
three problems simultaneously by developing a complex yet naturalistic foraging task for mice and applying
recently developed neurobiological techniques to record and manipulate neural activity in multiple brain regions
over long time scales. The long-term objective is to use this combination of behavioral and neurobiological
techniques to understand decision making in a naturalistic foraging context.
The proposed research investigates the hypothesis that foraging decisions are driven by neural integrator
mechanisms akin to those used to integrate sensory evidence for perceptual judgments, and require
bidirectional communication between cortex and striatum, which are often studied in isolation but in fact must
communicate to generate decisions. Simultaneous optogenetic perturbations and large-scale recordings will be
used to dissect the interplay between medial prefrontal cortex (mPFC) and dorsomedial striatum (DMS), which
of the many interconnected regions of cortex and striatum are among the most likely to contribute to the
integration processes needed to forage efficiently. Indeed, preliminary mPFC recordings show signatures of
temporal reward integration. Spatiotemporally precise optogenetic perturbations with simultaneous neural
recordings will reveal which aspects of this computation occur locally in mPFC and/or through corticostriatal
interactions. Finally, novel longitudinal electrophysiological recording techniques will answer how environment
value, a key variable in foraging decisions, is tracked over long time scales (days). This question has been
difficult to study in the past due to the technical challenge of tracking the same neurons over time scales longer
than several hours. Together, these experiments will advance the field’s understanding of how distributed
networks of brain areas solve a complex yet ethologically relevant decision-making problem. This will create
deeper knowledge of how the healthy brain tracks rewarding outcomes to make decisions, which is critical for
understanding what goes awry in dysfunctional states like addiction, obsessive compulsive disorder, and mood
disorders.
This project will take place in the Uchida Laboratory in the Department of Molecular and Cellular Biology at
Harvard University. The Laboratory and Department are well-equipped to support the proposed research and
provide rigorous postdoctoral training to the fellowship applicant.

Public health relevance
PROJECT NARRATIVE Understanding how the healthy brain makes decisions is critical for advancing human health, as decision making is often impaired in disorders including addiction, obsessive compulsive disorder, and mood disorders. This proposal leverages patch foraging, a naturalistic behavior that requires sophisticated decision-making abilities, to investigate the neural basis of decision making. The proposed research will combine a novel patch foraging paradigm with cutting-edge rodent neurobiological tools to further our understanding of naturalistic decision-making processes in the healthy brain.